Regulation of Dynein-Mediated Transport

PROJECT SUMMARY
Organization is a fundamental and defining feature of life at all degrees of scale, from the subcellular
level all the way up to the level of the organism. On the cellular level, molecules and organelles must be situated
with appropriate temporal and spatial precision such that processes may proceed according to the needs of the
cell. Similarly, cells are arranged into appropriate layers to define underlying tissue organization, which provides
the basis for organ function, and to support health of the organism. Major determinants of subcellular and cellular
organization are molecular motors that transport diverse cargoes throughout the cellular environment. One such
motor is cytoplasmic dynein, which transports numerous types of cargoes along microtubule tracks during all cell
cycle stages, and within many cell types. For instance, dynein is the major retrograde microtubule motor that
transports many vesicular and protein cargoes toward the cell body of neurons. In addition to orchestrating
appropriate subcellular organization, dynein plays a major role in the establishment and maintenance of tissue
architecture. For instance, a major determinant of cell fate and consequent tissue organization is the orientation
and position of the mitotic spindle with respect to the boundaries of the cell. In addition to localizing to the
membrane of small vesicular cargoes – from where it effects their transport – dynein motors are anchored at
the plasma membrane from where they orient and position the spindle through precisely tuned interactions with
microtubules. During such processes as organismal development and tissue homeostasis, spindle orientation
and position dictate the plane of cell division, and thus whether a cell divides symmetrically or asymmetrically.
Symmetric stem cell divisions result in two identical stem cells, whereas a switch to asymmetric division results
in one stem cell and a differentiated cell, which promotes tissue stratification. Thus, dynein is a critically important
molecule that dictates biological organization on many levels of scale. The precise mechanisms by which dynein
performs all these disparate functions with appropriate spatial and temporal control are unclear. The lack of such
information presents an impediment towards the development of effective therapies that may prevent or reverse
defects in cellular and tissue organization that can lead to various devastating disorders (e.g., malformations of
cortical development, motor neuron diseases). In the proposed studies, we will use a combination of in vitro and
cell biological approaches to determine the mechanisms by which dynein is regulated to perform its cargo
transport functions. Specifically, we will: (1) resolve the mechanism by which the lissencephaly-related protein
LIS1 initiates dynein-mediated cargo transport; (2) determine how dynein effects spindle movements with precise
directional precision; (3) determine how, and the molecular basis by which various critical regulators affect dynein
activity; and, (4) investigate the coordination and interplay between cell cycle state and dynein activity. Our
studies will provide critical insight into fundamental mechanisms that dictate transport of numerous cargoes with
spatial and temporal precision such that cellular and ultimately organismal health is established and maintained.

Public health relevance
PROJECT NARRATIVE The establishment and maintenance of healthy cells and tissues relies on the timely transport of numerous cellular factors to their respective subcellular destinations. Highly regulated molecular motors, such as cytoplasmic dynein, ensure the appropriate delivery of such cargoes such that the final destination matches the needs of the cell. The goal of our research program is to understand how dynein is regulated with a high degree of spatial and temporal precision to ensure that inappropriate transport, which is causative of various human diseases, does not occur.